K+ channel complexes: assembly, trafficking and function

The long-term goal of this research is to elucidate the molecular and cellular mechanisms that ensure potassium (K+) channels assemble with the appropriate membrane-embedded regulatory subunits for proper physiological function. N-glycosylation is a vital co- and post-translational modification that facilitates the assembly and trafficking of K+ channel subunits. Mutations that block glycosylation of KCNE K+ regulatory subunits have been directly linked to the genetic and drug-induced forms of cardiac arrhythmias (Long QT Syndrome). Accordingly, the two aims of this proposal investigate K+ channel subunit glycosylation in the ER, Golgi and plasma membrane: (1) We will determine the molecular and cellular bases of K+ channel subunit co- and post-translational N-glycosylation. (2) We will reengineer the cell's glycocalyx to fluorescently visualize K+ efflux from living cells.

Public health relevance
Potassium (K+) channels function as macromolecular protein complexes composed of membrane-embedded ion-conducting and regulatory subunits. Mutations that prevent the assembly, trafficking or function of these complexes give rise to neurological, cardiac, muscular, auditory, and respiratory diseases. By investigating the molecular and cellular mechanisms that ensure the assembly, trafficking and function of K+ channel complexes, we aim to understand how these proteins work in healthy individuals and provide alternative strategies for remedying those affected by channelopathies (ion channel-related diseases).